Addressing the wireless power problem: A low-power hybrid radio for neuroscience experiments

Project Summary
Closed-loop stimulation is key to the study and treatment of neurological disorders. However, largely due to
current wireless power demands, stimulation systems are restricted to wired connections, which impact
natural behavior, induce motion artifacts, and limit complexity of study design. While a few wireless recording-
only systems have been developed, the power demands of these devices prohibit the addition of wireless
electrical stimulation while staying within size and weight limitations for smaller animal models. These
limitations are roadblocks to the next phase of neuroscience research and clinical development.
In this Phase I, 1.5 year, STTR project, Spike Neuro is partnering with Duke University to develop a novel low
power hybrid backscatter radio frequency system to enable the commercialization of a series of wireless
recording and electrical stimulation headstages for small and large animal electrophysiology research. This
innovative wireless technology shifts the high-power demand features out of the headworn components to the
base station, significantly reducing battery size and weight enabling the addition of the electrical stimulation
components and allowing for more flexibility in recording only experiments.
This development work will result in two headstage options for small animals with 5 and 16 channels of recording
and 2 channels of electrical stimulation and two slightly larger systems for 32 and 64 channels of recording with
8 channels of electrical stimulation. Aim 1 focuses on the development of the 5 and 16 channel systems and the
electrical stimulation integration. Aim 2 will build upon the efforts in Aim 1 to expand the system to up to 64
channels with 8 channels of electrical stimulation. Both aims will also include hardware and software integration
with the Spike Neuro data acquisition system. Aim 3 will conclude with benchtop and in vivo validation of our
system to demonstrate successfully achieving key features needed for a commercial wireless recording and
stimulation headstage.
This proposal brings together a strong team of experts in wireless technology, electrophysiology, and
commercialization to develop a wireless system that meets the growing needs of the neuroscience community.
The Phase I work will result in a multiple headstage options ready for commercialization while informing
continued Phase II development. In our future work, we will continue to scale our system to increase channel
count and reduce the latency of the closed-loop electrical stimulation.

Public health relevance
Project Narrative While neuroscience research has made many advancements in the treatment of neurological diseases and disorders, the limitations of available research tools are creating roadblocks to the next wave of innovation. Spike Neuro is developing a new wireless neural recording and electrical stimulation system that will enable novel research studies focused on the treatment of neurological issues. This work will have the potential to inspire a renaissance of complex neuroscience studies spanning from small animals all the way to the clinical market.